Impact of hypoxia on lipid metabolism in obesity-driven breast cancer progression

PROJECT SUMMARY
While significant evidence has demonstrated that obesity increases the risk of metastasis, the molecular
mechanisms by which obesity contributes to the metastatic progression of breast cancer are unclear.
Furthermore, recent research in cancer development and progression has highlighted the role of hypoxia and
dysregulated lipid metabolism. Research from our team and others demonstrate that lipid accumulation, which
is associated with reduced patient outcomes, is greater in metastases compared to primary tumors.
Furthermore, hypoxia, which is increased in obesity in the primary tumor, leads to sustained increase in the
expression of specific genes after reoxygenation, a hypoxic memory. Our results demonstrate that hypoxic
memory results in the expression of fatty acid synthase (FASN), which is the rate-limiting step in fatty acid
synthesis, and pyruvate carboxylase (PC), which we have shown provides oxidative stress protection. In
addition, the inflammatory cytokine interleukin-6 (IL-6), which is elevated in obesity, enhances the expression
of CPT1A, the rate-limiting step in fatty acid oxidation (FAO) to supply energy. Our preliminary data show that
the expression of these three proteins and their functional consequences of increased fatty acid synthesis and
FAO are elevated in metastases compared to primary tumors. Thus, our preliminary results suggest that
hypoxia may set the stage for dysfunctional lipid metabolism, where increased lipid synthesis and utilization
occur concurrently with a balance towards lipid accumulation. However, the impact of dysfunctional lipid
metabolism in obesity-driven metastasis is unknown despite the supporting evidence that hypoxia and IL-6 are
enhanced in obesity. In the proposed studies, the research team will utilize multiple mouse models of obesity
and metastatic breast cancer to evaluate the mechanistic basis by which hypoxic memory and IL-6 interact to
stimulate obesity-driven breast cancer metastasis. They will test the hypothesis that obesity-associated
increases in hypoxic memory and proinflammatory IL-6 signaling work in tandem to increase FA accumulation
(FASN), FAO (CPT1), and cell survival (PC) to enhance metastases. These hypotheses will be tested through
the completion of the following two aims: 1) determine the impact of hypoxic memory on lipid accumulation in
obesity-driven metastasis, and 2) establish the interaction of hypoxic memory with chronic inflammation in
obesity-driven metastasis. These studies will provide foundational evidence for developing targeted strategies
to mitigate obesity-driven metastatic breast cancer.

Public health relevance
PROJECT NARRATIVE The world is facing a growing epidemic of obesity which, in addition to other consequences, increases the risk of death due to breast cancer metastasis. The proposed studies will elucidate key mechanistic details related to the interaction of a low oxygen environment (hypoxia) with the proinflammatory cytokine interleukin 6 that work in tandem to support aberrant lipid metabolism in obesity-driven metastasis. The results of these studies will contribute to making appropriate, targeted recommendations for preventing obesity-related metastasis.